Building a gene regulatory network-based model for cell fate specification and morphogenesis using a new mollusc model.

PARENT GRANT ABSTRACT
Cells are the fundamental units of all biological structures and phenomena—the evolution of
novel phenotypes and physiologies is ultimately the result of changes in cellular characteristics,
especially cell fate specification. Cell fate specification is well understood in established model
systems, and can be described and modelled by building gene regulatory networks (GRNs). It is
not well-understood how gene regulatory networks maintain vs modify their wiring over
evolution, by making and breaking connections between genes. One of the impediments to
making progress in this area is the lack of sophisticated GRNs outside of deuterostomes
(echinoderms, vertebrates, ascidians) and ecdysozoans (nematodes and arthropods). Unlike
these two well-studied clades, the Spiralia/Lophotrochozoa has not been used for GRN
analysis, despite the fact that this monophyletic group includes ~40% of extant animal body
plans, including familiar taxa like annelids and molluscs. Many members of the Spiralia begin
development with a common ground plan sharing a highly stereotyped pattern of spiral cleavage
and homologous cell lineages. Between these species, cell lineages can be homologized at
single-cell resolution across hundreds of millions of years of evolution. Yet Spiralian embryos
ultimately are transformed through morphogenesis into a vast array of diverse adult body plans.
Nowhere else can one undertake systematic comparisons at a single-cell level between body
plans; thus spiralians offer a unique opportunity for comparative developmental biology at the
level of morphology, molecular mechanisms, and homologous cell lineages. This proposal
argues that the slipper snail Crepidula is poised to make significant contributions to GRN
biology by being used to build the first developmental GRN among Spiralians. We outline a
strategy to build a comprehensive developmental gene regulatory network for every cell type in
Crepidula. This research will define: 1) the molecular mechanisms controlling the formation and
function of the Crepidula embryonic organizer and 2) the GRN controlling gastrulation. Studying
cell fate specification and morphogenesis in a wider range of animals will provide fresh insight
into the ways GRNs operate, and will provide a useful comparison for other model systems.

Public health relevance
PROJECT NARRATIVE Gene regulatory networks (GRNs) are valuable tools to compare and interrogate the genetic regulation of development across species as well as to pinpoint novel mechanisms of development. No bonafide developmental GRN currently exists among the clade Spiralia/Lophotrochozoa, one of the largest and most diverse groups of animals. The marine slipper snail Crepidula is particularly well suited for GRN studies because its embryology and fate map are well studied and its embryos are amenable to microinjection, allowing gene perturbation studies. This proposal leverages the existing knowledge of the function of the developmental organizer to dissect how it functions at a molecular level--specifically the role of MAPK signalling. This project will aid in the NIH’s mission to increase fundamental knowledge about the nature and behavior of living systems and its application to enhance health.